Obesity Research Center Training Grant

Project Summary/Abstract
This T32 post-doctoral training program, now in its 31st year, provides 2-3 years of fellowship designed to prepare
PhDs and physicians for investigative careers in obesity research. Of the fellows trained with support from this
T32 during the past 15 years, 92% remain in research (academic, industry) positions related to obesity and allied
disorders. Our Specific Aim is to train promising young scientists to become independent investigators focusing
on obesity-related issues. Our long-term objective is to increase the investigator pool working on the broad
biology of obesity and its co-morbidities. This program has important national implications since obesity is among
the foremost health problems facing America, imposing growing costs in terms of human suffering, health care
and productivity. There is a critical dearth of well-trained young investigators. We provide a structured curriculum
in the first 2 years (includes career development and grantsmanship), in combination with a research experience
emphasizing wide opportunities in basic laboratory and/or translational research, reflecting the great strengths
of Columbia University in these areas. Post-doctoral fellows are appointed at Columbia University, enabling
access to a wide array of formal courses throughout the University. The T32 has specified course requirements
that are attuned to the fellow’s previous experience and selected research project. Fellows participate in
seminars of obesity, diabetes, nutrition and other bioscience Centers of the University. Trainees elect to work
with a faculty member at Columbia and are incorporated into the investigative program of mentors at the New
York Nutrition Obesity Research Center and other laboratories. The faculty's multidisciplinary nature (physicians,
biochemists, cell biologists, pathologists, neuroscientists, psychiatrists, nutritionists, molecular biologists and
geneticists) allows a multi-disciplinary approach by the trainees. Strong collaborative ties among the training
faculty make this possible. Trainees have access to the entire spectrum of research tools in obesity biology,
ranging from structural/cell biology, molecular genetics and neuroscience through clinical investigation. Trainees
are (1) physicians who have completed 3 to 5 years of post-graduate clinical training, (2) recent PhD (or
equivalent) recipients in disciplines including (but not limited) to molecular genetics, biochemistry, nutrition,
physiology, neuroendocrinology, neuroscience, or pharmacology. Individuals are selected based on their
demonstrated competence in medical and/or graduate school, recommendations of their faculties, and
consideration of the extent to which their research interests are congruent with those of the Columbia faculty. All
trainees at time of entry must be pursuing an investigative career in obesity (including its complications) or
appetitive behaviors. An Individual Development Plan is created for each trainee and is monitored by an ad hoc
Scholarly Oversight Committee. Minority diversity is an explicit goal of the program. Each of the participating
faculty laboratories (n= 25: 7 Junior/18 Senior) is well equipped and funded to support a trainee's research.
Continued funding for 3 trainee slots per year for a 5-year award is requested.

Public health relevance
Obesity is now among the leading causes of medical morbidity and health care costs in the U.S. The regulation of body weight - and the impact of excess weight on clinical phenotypes such as diabetes, cardiovascular disease and cancer - is extremely complex necessitating special training in centers with broad basic and translational research portfolios for the scientists who will help to break this nexus of disease. The objective of this longstanding training program is to increase the young investigator pool working on the biology of obesity and its co-morbidities through academic course work and sophisticated research experiences, enabling them to become independent investigators who can assume leadership positions in this field. This program has important national implications by virtue of its provision of a critical group of bioscientists.